Training in Molecular and Cellular Biology

Use continuation pages as neededto provide the required Start with Principal Investigator. List all other key personnel in alphabetical order, last name first. Name ...................... _ Or_an!zat!o n.......................................... Carol A. Erickson DBS: Molecular and Cellular Biology Professor Steffen Abel CAES: _;egeiabie Crops ............. Assistant Professor Enoch P. Baldwin DBS: Molecular and Cellular Biology Assistant Professor Everett Bandman C AEs: Food Scienceand Technology Professor Anne B. Britt poundiBS: i3iant ]3ioiogy ...... Associate Professor Scan M. Burgess [unreadable] DBS: Molecular and Cellular Biology Assistant Professor Disclosure Permission Statement. Applicableto SBIR/STTR Only. See instructions. [] Yes PHS 398/2590 (Rev. 05/01) Page 2 information in the format shown below. Ro!e on.prgjepoundt % Eff9rt Principal 10% Investigator Trainer 5% _i;rainer 5% Trainer i5% Trainer ' ' Trainer ..... [] No Continuation Format Page Principal Investigator/Program Director (Last, first, middle): Erickson, Carol A, Name Or_ar2ization Role on